LOGISTICAL AND IT SUPPORT FOR THE NCI CENTRAL INDIVIDUAL REVIEW BOARD (CIRB)

The NCI Central Institutional Review Board is dedicated to protecting the rights and welfare of participants in cancer clinical trials. Institutions across the country rely on the CIRB national experts to ensure that clinical trials are reviewed efficiently and with the highest ethical and quality standards. The NCI CIRB helps reduce the administrative burden on local IRBs and investigators while continuing a high level of protection for human research participants. CIRB, with one centralized review, enables investigators to enroll patients into Network trials significantly faster than when employing the traditional method of assessment, which requires trial investigators in each site to obtain approval from a local IRB.